Supplement for Neural mechanisms of early visual dysfunction in psychosis

Project Summary
Psychosis is a serious mental disorder involving disruptions in neural processing that are poorly understood. In
addition to disrupted cognition, abnormal sensory processing is also found in psychosis, including distorted
perception and hallucinations. This proposal will apply tools from visual neuroscience in order to gain insight
into the neural basis of abnormal visual perception in psychosis. Because visual neural circuits are well-
understood in animal models, we will be able to test a very specific hypothesis about the nature of visual circuit
disruptions in psychosis; that this disorder is associated with abnormally weak early visual gain control. Gain
control is a neural process that prevents responses to strong visual stimuli from becoming too large. It is known
that in psychosis, some visual illusions are perceived as weaker than in healthy adults due to abnormally weak
gain control. We will use a visual paradigm designed to tap into particular neural circuits in combination with
EEG, in order to pinpoint the neural basis of this visual abnormality. In addition, we will acquire longitudinal
measures of visual gain control and psychosis symptoms, in order to test the hypothesis that weaker gain
control is associated with clinical deterioration. Finally, using functional MR spectroscopy, we will examine the
role of glutamate in occipital cortex during visual processing in psychosis. This work will elucidate the
pathophysiological mechanisms of psychosis, thereby facilitating the development of more precisely targeted,
etiologically-based treatments.

Public health relevance
Project Narrative People with psychosis see the world differently than others (e.g., hallucinations), and they do not see some visual illusions as strongly as healthy people do. Because we have a good understanding of visual brain systems from animal research, we can pinpoint the problem with seeing an illusion to a particular neural circuit. This project will use techniques from visual neuroscience along with EEG, magnetic resonance spectroscopy, and behavioral measures to uncover how psychosis disrupts visual perception.